EXERCISE OPTION 2 FOR BPA ORDER TITLED "USER CENTERED RESEARCH AND ANALYTICS" AGAINST THE NHLBI OSPEEC BLANKET PURCHASE AGREEMENT (BPA) TASK AREA 5.

BPA Task Area 5 Order titled "User Centered Research and Analytics"
• Provide professional user centered research and digital analytics services to support the NHLBI public-facing website and other digital platforms, which serve as primary communications channels for the Institute.